Advanced Microscopy

The Advanced Microscopy Facility, formerly the Central Electron Microscope Facility, has undergone a major expansion in terms of equipment and services offered since the last CCSG renewal. The facility, which is both a full-service and a user-facility, has been expanded from primarily an electron microscopy center to encompass a full range of light and electron microscopy technologies. This expansion includes the acquisition of four confocal microscopes and one transmission electron microscope, and relocation of the facility to renovated quarters, doubling the previous laboratory space. The primary objective of the facility is to provide investigators access to, and assistance with, state-of-the art confocal and electron microscopes, preparatory equipment, and applications. A new emphasis of this Shared Resource is to provide facilities for the manipulation and imaging of live cells, and to track the dynamics of fluorophores in cells under physiological conditions. Within this overall framework, related objectives include: (1) providing consultation on research objectives which employ electron and light microscopy methods;(2) assuring that up-to-date equipment is available and properly maintained for use by investigators;(3) providing complete electron microscopy specimen preparation services;(4) educating and training clients in the use of equipment or specialized techniques;and (5) monitoring developments in the field of microscopy that might be incorporated into the services offered by the facility.